Unique ADP-ribosylating and vacuolating properties of Mycoplasma pneumoniae CARDS toxin trigger airway inflammation and disease progression

Abstract
Mycoplasma pneumoniae is the leading cause of bacterial pneumonia in children hospitalized with
community acquired pneumonia (CAP) and the second most common cause of bacterial CAP in adults in the
United States. Persistent and recurring M. pneumoniae infection leads to severe respiratory disorders,
including asthma and COPD, and a range of extrapulmonary pathologies. Until recently, it was unknown how
a respiratory pathogen, like M. pneumoniae, induces cytopathology and exaggerated inflammatory
responses that cause airway injury, dysfunction and remodeling. We identified a novel M. pneumoniae ADP-
ribosylating and vacuolating toxin designated Community Acquired Respiratory Distress Syndrome (CARDS)
toxin. CARDS toxin alone elicits the characteristic airway inflammation, lung histopathology, cellular
vacuolation, mucus metaplasia and pulmonary dysfunction in intoxicated rodents and primates that are
observed during infection with M. pneumoniae. The amino terminal domain of full length (FL) CARDS toxin
(i.e., N-CARDS) retains ADP-ribosyltransferase (ART) activity. N-CARDS selectively ADP-ribosylates NLRP3
of the NLRP3 inflammasome complex, resulting in inflammasome activation and subsequent release of IL-
1β, a potent pro-inflammatory cytokine. In preliminary results, we also show that CARDS toxin selectively
ADP-ribosylates serine hydroxymethyltransferase (SHMT2), which is involved in one carbon metabolism, and
EF1γ, which is involved in the transfer of aminoacyl-tRNAs to the ribosome. The unique carboxyl region of FL
CARDS toxin (i.e., C-CARDS) selectively binds to receptors surfactant protein-A (SP-A), annexin A2 (AnxA2)
and phospholipids, phosphatidylcholine (PC) and sphingomyelin (SM). Internalization of FL CARDS toxin
follows receptor-mediated binding, with subsequent ADP-ribosylation of host target proteins, vacuolation,
hyperinflammation and cell/tissue histopathology and injury. Interestingly, C-CARDS alone causes both
vacuole formation in human cells and eosinophilic inflammation in naïve mice, leading to an asthma-like
phenotype. In this proposal, we intend to identify how ART and vacuolating properties of CARDS toxin trigger
pro-inflammatory and pathologic responses in human WT, silenced or knockout cells and in WT and
knockout mice. Based on our preliminary results, we hypothesize that both ADP-ribosylating and vacuolating
activities contribute to the overall ability of CARDS toxin to initiate and sustain disease pathogenesis. We
plan to test this hypothesis by – a) studying how CARDS toxin ART activities initiate inflammatory pathways
and cytopathology, b) elucidating the role of receptor binding in CARDS toxin-mediated inflammation, c)
characterizing how vacuolating activity promotes airway inflammation and injury, and d) analyzing the in vivo
involvement of select ART and receptor targets in triggering CARDS toxin-mediated airway inflammation and
lung pathology. Understanding the mechanisms by which ART and vacuolating activities of CARDS toxin
regulate host response should lead to therapeutic interventions and improved societal well-being.

Public health relevance
Public Health Relevance: The proposed project asks fundamental and applied questions concerning the role of Mycoplasma pneumoniae (Mp) ADP-ribosylating and vacuolating toxin, designated Community Acquired Respiratory Distress Syndrome (CARDS) toxin, in airway pathogenesis. Furthermore, this study should uncover molecular mechanisms by which CARDS toxin uniquely contributes to hyper-inflammation and airway injury. Information generated will substantially advance our understanding of Mp disease pathogenesis and should lead to effective and improved treatment modalities.